Quantum sensor-enabled nanoscale magnetic resonance

Project Summary:
Magnetic resonance experiments are an indispensable tool in biophysics, providing detailed chemical insight
and accessing unique degrees of freedom. However, these methods have poor sensitivity compared to
fluorescence techniques, requiring low temperatures and/or concentrated sample conditions, which presents a
roadblock to their wider utilization. The long-term goal of this project is to develop novel quantum sensor-
enhanced magnetic resonance techniques which can reach the single-molecule regime, with the specific
applications to electron transport in metalloproteins and nanoscale motion in membranes. The objective of this
proposal is to develop novel strategies for integrating these quantum sensors (the NV center in diamond) with
proteins and biomembranes. Our innovation is a suite of experimental strategies to improve the sensor
compatibility with biological systems, ranging from minimizing photodamage using a total internal reflection
geometry, to localizing targets at the sensor surface with supported lipid bilayer formation. Our rationale for this
overall approach is that NV centers have found extensive applications in condensed matter physics and materials
science because of their outstanding performance as magnetic resonance sensors, yet progress in biophysical
contexts has been much slower because of the more demanding nature of the biological samples. Addressing
these challenges would allow us to leverage the uniquely-powerful properties of the NV center – picotesla
sensitivity, fluorescence readout, single-spin detection – to enhance the capabilities of magnetic resonance
(NMR, ESR) techniques. The first research direction this new tool will enable is probing electron transfer in
metalloproteins; we will be able to, at room temperature, probe the Fe-heme spin in cyctochrome c (and related
proteins) to access spin and conformational information, while also probing time-dependent behavior to extract
electron transfer rates. Our hypothesis here is that the complex spin-state behavior of Fe ions (e.g., admixture
states first identified in the 1970s) is a functionally-important factor in electron transport, and which will be
required to explain a range of novel behaviors in heme protein superstructures, such as metallic conduction and
spin-dependent transport. Our second research direction focuses on probing diffusion on the <10nm length
scale, beyond the limits of even most super-resolution techniques. Our hypothesis here is that nanoscopic
domain formation (which we will induce with multicomponent lipid compositions) will introduce significant
deviations from Brownian diffusion, and that experimentally measuring this will provide new insight into motion
in confined environments in cell membranes. This research is significant because improved sensitivity in
magnetic resonance experiments would enable transformative new research across multiple fields, and the
specific areas we identify here will address long-standing, fundamental biophysical questions. This research will
have a positive impact because the new tool we will develop can be broadly applied by other groups, and the
new insight we develop will enable broadly applicable mechanistic principles to be articulated.

Public health relevance
Project Narrative: The proposed research is relevant to public health because the knowledge gaps we identify – electron transfer in metalloproteins and nanoscale behavior of biomembranes – are essential to biological function and gaps in our understanding preclude a truly molecular description of these processes. This proposal aims to develop new nanoscale magnetic resonance approaches to address this and apply these new methods to uncover new structure-function relationships in metalloproteins and systematically explore the effects of confinement in membranes. Thus, this proposal is relevant to the part of the NIH’s mission which seeks to develop fundamental knowledge about the nature of living systems, expand the knowledge base in biological research, and develop new tools for probing biological processes.